COLLABORATIVE EPIDEMIOLOGIC CANCER RESEARCH IN CHINA

Provision of administrative and scientific personnel to develop protocols for epidemiologic studies. Conducting of pilot studies whereby sample will be collected to evaluate feasibility of studies.